Neuroengineering and Fabrication Module

Project Summary
Vision science is rapidly evolving to include increasingly interdisciplinary applications involving optics,
electronics, and software together with new hardware and custom machines, requiring expertise in engineering
and electronics which many individual laboratories lack. The Neuroengineering and Fabrication Module has
been established to meet current and future needs in these areas by providing integrated technical and
customized engineering support to the Harvard vision research community. In addition to aiding in the design
and fabrication of custom optical and electronic devices and their associated software, a second major focus of
the Neuroengineering and Fabrication Module is to provide training in the design and implementation of these
methods for the wider vision research community. The Neuroengineering Module, for example, hosts regular
instructional classes on the use of electronics for neurobiology applications. Under the guidance of Module
Director Dr. Margaret Livingstone, the Neuroengineering and Fabrication Module will continue to provide easily
accessible expertise and resources to allow for the rapid prototyping and exploring of new experimental
techniques and approaches, thereby catalyzing innovation and creativity across the wider Harvard vision
research community.